Seek, Test, Treat Strategies for Vietnamese Drug Users: A Random Controlled Trial

DESCRIPTION (provided by applicant): Injection heroin use and HIV/AIDS are major public health problems in Vietnam, with HIV infection continuing to be concentrated among the growing injection drug use (IDU) population (20% HIV prevalence, nationally). Although considerable progress has been made to expand HIV prevention and antiretroviral therapy (ART) programs, the high HIV transmission rate among IDUs continues (HIV incidence, 5% per year), access to antiretroviral therapy still limited (11%), and mortality among HIV-positive drug users remains excessive (15% per year), requiring interventions. The Vietnamese government's approach to drug demand reduction has primarily relied on its system of 83 drug treatment centers (DTC) where most detainees (85%) are admitted through arrests by police. Relapse to opioid injection after such treatment is 71% within 6 months after release from DTCs. DTCs represent a unique opportunity to identify, test, and provide ART to a large segment of this marginalized population. We propose an intervention that employs the seek, test, and treat strategies for the IDU population and their network members, by ensuring that high risk individuals are sought for HIV testing, promptly referred to and maintained on ART, while HIV prevention interventions provided to the many who test HIV-negative, as well as those who test HIV-positive. The intervention will seek and test IDUs via DTCs using CDC-recommended routine opt-out HIV testing in criminal justice settings and also will seek and test their network members. HIV-positive IDUs will be referred to HIV care through a two arm randomized controlled trial to compare the effects of different levels of engagement in care on ART uptake, antiretroviral adherence, and treatment outcome. The total duration of the trial will be five years. The study will be conducted in all participating DTCs in the capital city of Hanoi

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposed research is to respond to the RFA-DA-10-017. The seek, test and treat intervention being studied is designed based on epidemiologic evidence to address major issues in testing, treatment and care for Vietnam's highest HIV risk population. The intervention will be integrated into government systems for drug treatment and HIV/AIDS services and will supplement existing HIV prevention and care efforts. Project Narrative This proposed research is to respond to the RFA-DA-10-017. The seek, test and treat intervention being studied is designed based on epidemiologic evidence to address major issues in testing, treatment and care for Vietnam's highest HIV risk population. The intervention will be integrated into government systems for drug treatment and HIV/AIDS services and will supplement existing HIV prevention and care efforts. __SpecificAimsTextDelimiter__ Program Director/Principal Investigator (Last, First, Middle): Quan, Vu Minh 1. SPECIFIC AIMS Substance abuse is a growing public health problem in Vietnam. The number of drug users known to governmental authorities increased 70% to 170,000 between 2000 and 2004. Drug users in Vietnam are heavily affected by the HIV epidemic, with approximately 20% HIV sero-prevalence nationwide in 2009, compared to <1% HIV sero-prevalence in the general population. Only 11% of HIV-infected injection drug users (IDUs) who require antiretroviral therapy (ART) have access to treatment. The mortality among HIV- infected IDUs is excessive, even among those who are on ART (15% per year). The Vietnamese government's approach to drug demand reduction has primarily relied on its system of approximately 83 drug treatment centers (DTC) that provide short-term detoxification (using depressants, analgesics) for 2-4 weeks, followed by 1-5 years of re-education, vocational training, and manual labor. Most detainees (85%) are admitted through arrests by police. Over half of IDUs enter a DTC at some point during their drug-using career and relapse to drug use is 71% within 6 months after release from DTCs. While several programs provide HIV-infected drug users with ART in detention, detainees are not routinely tested for HIV and there are no programs focusing on providing HIV-positive drug users with ART after being released from detention. There is strong evidence that drug users have lower rates of ART adherence than other HIV-positive populations and that adherence dips with frequent drug use. DTCs represent a unique opportunity to identify, test, and provide ART to a large segment of this marginalized population. We propose an intervention that employs the seek, test, and treat strategies for the IDU population and their network members, by ensuring that high risk individuals are sought for testing, promptly referred to and maintained on ART, while HIV prevention interventions provided to the many who test HIV-negative, as well as those who test HIV-positive. Vietnam is now building infrastructure to enable these interventions and the proposed study will supplement HIV prevention and care efforts in the capital city of Hanoi. The intervention will seek and test IDUs via DTCs using CDC-recommended routine opt- out HIV testing in criminal justice settings and also will seek and test their network members. HIV-positive IDUs will be referred to HIV care through a two arm randomized controlled trial to compare the effects of different levels of engagement in care on ART uptake, ARV adherence, and treatment outcome. The proposed research aims are: 1) Seek and Test I: To examine the uptake of HIV testing and cost-effectiveness of implementing the CDC-recommended routine opt-out HIV testing strategy for drug users detained in DTCs in Vietnam. 2) Treat: To conduct a prospective, randomized, controlled trial to determine the effects of a structured, novel intervention on increasing access to HIV and addiction care and on improving antiretroviral adherence and treatment outcome for among HIV-positive male drug users released from DTCs in Vietnam. Drug users who are HIV positive and meet criteria for initiating ART according to Vietnam's national guidelines will be screened and randomized (n = 600) to intervention arm or control arm in a ratio of 1:1.3 before release from DTCs. Participants in the control arm will receive referrals for ART at public HIV clinics and for methadone at public drug clinics, where they will receive standard care regimens. Those in the intervention arm will be referred to an integrated methadone-ART clinic [iMART], with outreach to facilitate referral and telephone support to facilitate adherence, as well as administered antiretroviral therapy [DAART] if they become non-adherent. Primary outcome measure is time from release to the initiation of ART. Secondary outcome measures are self-reported antiretroviral adherence; changes in CD4+ counts; HIV-1 RNA levels < 400 copies/mL at months 6 and 12, and quality of life. 3) Seek and Test II: To evaluate the extension of HIV voluntary counseling and testing to social network members of ex-detainees. It is hypothesized that network members of the HIV-positive ex- detainees are also at elevated HIV risk and that a recent favorable HIV testing experience of enrolled participants plus an incentive for future testing will lead to an increase in HIV testing uptake among the ex- detainees' social network members. Each former detainee will receive 5 bar-coded vouchers to be distributed to network members for redemption at public VCT sites when the network members receive anonymous HIV counseling and testing. HIV-infected individuals will be referred for ART at public HIV clinics. We will evaluate the uptake of this incentivized network-based referral, as a way of extending the reach of seek and test strategies for IDUs' network members. The total duration of the trial will be five years. The first 12 months will be devoted to formative research and trial setup. The planned accrual period for the trial is 24 months with individual follow-up period of 18 months following enrollment. The study will be conducted in all participating DTCs in Hanoi.